Cell cycle regulation in the cephalic epithelium as a driver of midface morphogenesis

PROJECT SUMMARY
Cleft lip with or without cleft palate (CL/P) is the most common craniofacial birth defect in humans. During
embryogenesis, the medial, lateral, and maxillary prominences of the midface must fuse at a site called the λ
junction to form the upper lip and primary palate. Previously, our lab discovered roles of the midface epithelium
during fusion, including: 1) the coordination of epithelial dissolution via two discreet cell populations undergoing
apoptosis and epithelial-to-mesenchymal transition; 2) in murine models of CL/P deficient in PBX genes these
epithelial subpopulations are absent; and 3) only half of the epithelial cells removed were accounted for by
these processes. This led our lab to investigate further the presence of novel subpopulations in the midface
epithelium. In performing single cell RNA sequencing of mouse midface epithelium alone, during fusion stages,
several subpopulations were identified and validated in vivo. I found that one subpopulation possessed a
unique transcriptomic signature wherein enrichment for cell cycle arrest genes and depletion of cell cycle
progression gene transcripts coincided with the expression of genes implicated in mouse and human CL/P
pathogenesis. My in vivo analysis found this subpopulation of cells was spatio-temporally localized to the site
of λ fusion, leading us to name these cells “λ fusion effectors.” I hypothesize that the λ fusion effectors are
implicated in the pathogenesis of CL/P and that cell cycle arrest is a yet uncharacterized mechanism
tied to prominence fusion. To better understand this epithelial subpopulation and the role that the cell cycle
plays during midface fusion, I propose to 1: Assess and track cell cycle progression and arrest in λ fusion
effector cells during upper lip/primary palate morphogenesis and fusion in wild type conditions. I will
assess subpopulation dynamics in vivo by conducting EdU/BrdU dual labeling of mouse embryos and I will
track cell cycle phase changes ex vivo by using an explant system from FUCCI mouse embryos. 2: Establish
the molecular mechanisms underlying cell cycle arrest in λ fusion effector cells during upper
lip/primary palate morphogenesis and fusion in wild type conditions. I will isolate and quantify λ fusion
effector cells from the distal prominence tips using cytometry approaches and will identify PBX1 gene targets,
with a focus on cell cycle arrest genes, in the isolated subpopulation of λ fusion effector cells versus
neighboring λ epithelium. Aim 3: Determine if, in our mouse model of CL/P, embryos with compound loss
of Pbx1/2 exhibit changes to cell cycle arrest in the epithelial λ fusion effector subpopulation. I will
quantify and assess perturbations in the λ fusion effector cell subpopulation in Pbx1/2 mutants with CL/P. My
research will investigate the molecular mechanism of cell cycle arrest during fusion of the λ junction and how it
pertains to CL/P pathogenesis. Given the genetic links of this subpopulation to human CL/P, it is my hope that
this study will provide novel targets for CL/P early prenatal diagnosis, prevention and treatment, and uncover
mechanisms of cell cycle arrest with broad implications in tissue fusion, repair and morphogenesis.

Public health relevance
PROJECT NARRATIVE Cleft lip with or without cleft palate (CL/P) represents the most common craniofacial birth defect and is a burden for the individual and society. I will investigate the cell behaviors, genetic pathways, and regulatory networks underlying facial prominence fusion to identify new genes that will enable rapid prenatal diagnostics and tissue repair of CL/P.